Cancer Center Support

DESCRIPTION (provided by applicant): The University of Pittsburgh Cancer Institute (UPCI) is a multidisciplinary cancer research center, with programs in basic research, translational research and clinical investigations; cancer control and population sciences, early diagnosis and treatment, and behavioral medicine research. In addition to its central role in all cancer research at the University of Pittsburgh, it has full responsibility for cancer education and a recently significantly expanded network of clinical care. The UPCI is comprised of faculty members from the University of Pittsburgh, with some members also from the nearby Carnegie Mellon University, and it utilizes the clinical facilities of the University of Pittsburgh Medical Center (UPMC) and UPMC Cancer Centers. The UPCI has established programs in: molecular and cellular oncology, molecular therapeutics and drug discovery, immunology, molecular virology, lung and thoracic malignancies, prostate and urologic cancers, head and neck cancer, biological therapeutics, brain tumors; cancer epidemiology, prevention and control; and behavioral medicine and oncology. To assist its research efforts, the UPCI maintains shared facilities including: Biostatistics, Clinical Research Services, Immunologic Monitoring Laboratory, Cellular Products Laboratory, Flow Cytometry, Peptide Synthesis, Animal, Glassware, Oligonucleotide, Cell and Tissue Imaging, PET, MRI, Basic Genomics and Proteomics, Clinical Proteomics, Vector, Transgenic and Chimeric Mouse, Tissue and Research Pathology Services (TARPS), Clinical Pharmacology and Analytical, Cancer Informatics Services, Investigational Drug Service, and Micro-array and Analysis Shared Services(MASS). This application requests continued cancer center support grant (CCSG) funding for the University of Pittsburgh Cancer Institute's program for years 17-22.